Cryo-EM structure of a membrane-embedded glutamate receptor

DESCRIPTION (provided by applicant): A long-pursued goal of structural biology has been the determination of the structure of membrane proteins in their native membrane environment, and in their various functional states as defined by transmembrane gradients of substrate molecules and membrane potentials. Application of such gradients, let alone crystallization in a membrane environment, has not been possible in the case of X-ray structure determination. The application of gradients has remained out of reach as well for the analysis of 2D crystals by electron crystallography. The proposed work concerns the further development of a general method for single-particle cryo-EM structure determination of membrane proteins reconstituted into liposomes. The method is called random spherically- constrained (RSC) single-particle reconstruction. In the proposed work we will work to surmount several remaining technical hurdles, and then apply this combination of biochemistry, EM imaging and image processing methods toward a nanometer- resolution structure of the GluA2 glutamate receptor as reconstituted into a lipid membrane.

Public health relevance
PUBLIC HEALTH RELEVANCE: In order to understand the detailed workings of the molecular machines that underlie life, one needs to examine their three-dimensional structures. In the proposed work we will work to surmount several technical hurdles to obtain 3D structures of GluA2 glutamate receptor in a membrane environment. This glutamate receptor is an essential signal- reception machine in brain cells.